IGF::OT::IGF THE RESEARCH INSTITUTE FO FOX CHASE CANCER CENTER DUNS: 064367329 CONTRACT ORIENTATION AND KICK-OFF MEETING - HHSN2612012000321 POP 09/22/2015-12/31/2015

The purpose of this Task Order is to hold an orientation/kickoff meeting to discuss Standard Operating Procedures (SOP) for all Contractors awarded an Indefinite Delivery, Indefinite Quantity (ID/IQ) contract for the PREVENT .Preclinical Efficacy and Intermediate Endpoints Biomarkers acquisition